Examining Sexual Dimorphisms: The Role of Estradiol Signaling in Modulating Immunity

Project Summary
Sexual dimorphisms associated with immunity and autoimmunity are well described. In some instances, these
differences have been attributed in part to estradiol or androgen hormone production and signaling; however,
while mechanistic data relating steroids to immune function are emerging, there are still significant gaps in our
knowledge. Our lab became interested in estrogen effects on the immune system as a result of our work on an
unusual disease called lymphangioleiomyomatosis (LAM). LAM is a rare cystic lung disease found almost
exclusively in women. The cystic lung changes are caused by small multifocal smooth muscle cell clusters in
the lungs that contain mutations in one of the two tuberous sclerosis (TSC) genes. In patients, LAM is highly
estrogen sensitive, as it worsens with puberty, pregnancy, and oral contraception, and stabilizes after
menopause. To explain the remarkable female predominance of LAM, as well as its estrogen sensitivity, we
proposed that LAM smooth muscle cells in the lungs may originate from the myometrium of the uterus. In fact,
when we knocked out TSC2 expression in the uterus, all mice developed aggressive myometrial growth that
resembled LAM, with 50% developing lung myometrial nodules from the uterus later in life. Mouse TSC2-null
uteri were highly sensitive to estradiol, as growth was eliminated with oophorectomy or aromatase inhibitor
treatment. In contrast, isolated LAM cells from these mouse uteri, as well as other TSC2-null cells, had little
estradiol sensitivity in vitro, suggesting that, in vivo, estradiol promotes LAM progression indirectly.
Accordingly, we find that estradiol via ERα stimulates innate immunity in mice by promoting neutrophil
production in the bone marrow. We have further shown that neutrophils stimulate TSC2-null myometrial cell
growth in large part through the release of neutrophil elastase (NE). Finally, we find that estradiol stimulates
expression of a melanocytic marker, GPNMB, and define it as a novel LAM serum biomarker that also serves
as a potential therapeutic target. Here we propose to examine the mechanisms by which estradiol enhances
neutrophil production in the bone marrow, as well as how estradiol and neutrophils act locally within the TSC2-
null myometrium to promote LAM progression. We will also examine how estradiol-induced GPNMB modulates
TSC2-null tumor cell growth, focusing on its possible actions as a T-cell suppressor. This work will uncover
novel mechanisms of estradiol-mediated changes in immunity that will apply to all aspects of biology, from
tumor physiology to infectious diseases to autoimmunity.

Public health relevance
Narrative Our laboratory studies how estrogen modules immunity to promote progression of a rare and devastating lung disease found almost exclusively in women called lymphangioleiomyomatosis (LAM). In human patients and in animal models, estrogen promotes progression of LAM; however, estrogen does not only directly stimulate LAM cells - instead, it also enhances neutrophil production and activation and inhibits T cells, both of which lead to LAM progression. Understanding these mechanisms will apply not only to LAM but to many other cancers.